The Metagenomics Education Partnership: Harnessing the Power of Microbial Genome Sequencing and Big Data with High School Students and Teachers.

The Metagenomics Education Partnership: Harnessing the Power of Microbial Genome Sequencing and Big
Data with High School Students and Teachers will further an ongoing partnership between the Department of
Biotechnical and Clinical Laboratory Sciences (BCLS) of the University at Buffalo Jacobs School of Medicine
and Biomedical Sciences, the New York State Area Health Education Center System (NYSAHEC), the Center
of Excellence in Bioinformatics & Life Sciences at the University at Buffalo and the Buffalo Niagara Waterkeeper
(BNW) with underserved/disadvantaged schools across a 14-county region of Western New York. The proposal
activities will 1) develop and strengthen partnerships between local high schools, colleges, biotechnology
companies, and local not-for profit organizations and serve as a pipeline for recruiting students to scientific and
health-related careers, with an emphasis on those from underrepresented groups; 2) utilize community-linked
citizen science involving metagenomic analyses of water samples in Western New York with underserved high
school students, empowering them to assist in safeguarding local water resources for present and future
generations; and 3) allow high school students and teachers to sequence and analyze a microbial genome,
supporting their explorations of Big Data, STEM and health-related careers related to genomics. Proposal
participants will be among the first high school students and teachers to use third generation Oxford Nanopore
MinION sequencing technology, giving them first-hand experience with the preparation of genomic DNA samples
for sequencing, in school DNA sequencing, tools for determining the makeup of microbial communities from
sequencing data, and the construction of a microbial genome through the compilation of a large number of
overlapping long MinION sequence reads. The project will include a week-long teacher professional
development covering hands on experience with all aspects of project activities in the summer, followed by three
different day-long refresher training sessions for teachers during the school year. Students will perform identical
project activities during the academic year under the guidance of their teachers and faculty from the partnership.
Year one of the proposal will be formative, involving two schools and three teachers along with a total of 30
students. Years 2-5 will have ten intervention teachers and 100 students per year take part, who will be
compared with a total of 30 teachers and 300 students as matched controls in years 2-4 as part of the evaluation
plan. Students and teachers will present data at an annual capstone event each spring. Their data on waterway
quality will in addition be shared and publicized by BNW, and their microbial genome sequencing data will
ultimately be shared on GenBank. The authentic research experiences for students involving new DNA
sequencing technology and big data manipulations will increase their interest, engagement and future
performance in STEM, and positively influence their long-term STEM and health-related career goals.

Public health relevance
This Metagenomics Education Partnership will immerse students and teachers within a citizen science research project focusing on assessing waterway health within the Western New York region consistent with the goals of the NIH Science Education Partnership Award (SEPA) R25 program. It will involve a novel third generation sequencing platform to determine the composition of the microbial communities present in those waterways, and to perform complete sequencing of one of the microbial genomes in the sample. The project will promote the role of genomics education in workforce development by informing high school students, educators and other relevant organizations how genomics integrates into future STEM jobs and careers.